IN VIVO ENDOTHELIAL INJURY AND DEPENDENT VASOMOTION

To test whether segmental coronary arterial impairment of EDVR correlates with the extent of endothelial injury before and after reduction of elevated triglycerides and cholesterol and cessation of smoking.